MU Alcohol Research Training Summer School (MU-ARTSS)

This application proposes to continue, refine, and disseminate a nine week summer research program in
alcohol and addiction research. The program, the “MU Alcohol Research Training Summer School” (MU-
ARTSS) at the University of Missouri, is targeted at undergraduate students with the goal of preparing trainees
for graduate training in health-related scientific disciplines focusing on alcohol and addiction research. The
program recruit seven students annually, drawn from a national pool of applicants, and with a major emphasis
on recruiting students from under-represented groups in STEM and biomedical disciplines (i.e., ethnic and
racial minority, economically disadvantaged, and first-generation college students). The MU-ARTSS program
consists of a one-week intensive set of didactic lectures on alcohol research. Didactic topics include:
introduction to and overview of addiction research, epidemiology, genetics, neuropharmacology,
neurophysiology, individual differences, assessment and treatment, responsible conduct of research, and
human subjects issues. In addition, trainees will attend laboratory demonstrations of addiction-relevant
research protocols, including mobile and ambulatory assessment, structural and functional neuroimaging, and
laboratory administration of alcohol to human subjects. Following this week of didactics, students will complete
an eight-week internship in the lab of a mentor conducting alcohol research. Through the internship period,
MU-ARTSS trainees will attend a weekly seminar series covering specific research skills and professional
development issues. A weekly “movie night” will be hosted by the program Co-Director, and will showcase
notable films about alcohol spanning more than 80 years of film history, allowing for less-formal discussion and
exploration of clinical phenomena related to alcohol and addiction, and the role and portrayal of alcohol in
society. The MU-ARTSS program will be supplemented by additional training programs and experiences
offered by the MU-Summer Research Internship Program (MU-SRIP). Partnering with MU-SRIP affords our
trainees an opportunity to interact with research faculty and students across multiple scientific disciplines and
in multiple venues including a Professional Development series, further instruction in the responsible conduct
of research, a lecture series, and a formal end-of-the-program poster session. The program draws on the large
number of active alcohol research programs in MU’s Department of Psychological Sciences. The focus of MU-
ARTSS on undergraduate education also provides an important complement to the alcohol training emphasis
at the graduate and postdoctoral levels (currently supported, in part, by a T32 to Co-Director Sher). To date, 12
MU-ARTSS interns have completed their undergraduate degrees, and of these, 7 are enrolled in Ph.D.
programs, 1 in an M.D. program, and 2 in Master's programs, all in STEM fields. Based on these initial
successes, the current proposal aims to continue refining MU-ARTSS recruitment and curriculum activities,
and importantly, begin disseminating materials and outcome data produced by the program.

Public health relevance
Project Narrative This program will support the continuation of a nine-week summer research program designed to facilitate the entry of promising young scientists into the field of alcohol and addiction research. The program provides trainees with a week-long series of lectures, followed by an eight week “hands-on” research internship, combined with a range of other training experiences throughout the internship period. The program is intended to enhance the knowledge, skills and experience of undergraduate participants and to prepare them for graduate school and careers as research scientists in health-related disciplines.